Pediatric Dermatology Research Alliance Annual Conference

DESCRIPTION (provided by applicant): Pediatric dermatologists care for children with a broad range of rare and common disorders, such as severe inflammatory skin diseases that require systemic therapy, disfiguring vascular birthmarks, and genetic skin disorders that can be life-endangering. There is a paucity of FDA-approved therapies for these severe conditions and a great need for standardized treatment protocols and methods to measure response to therapy. The Pediatric Dermatology Research Alliance (PeDRA) was established to address this therapeutic shortfall. PeDRA's vision is to create and sustain collaborative research networks that conduct well-designed, high-quality multicenter studies to better understand, prevent, treat and cure dermatologic diseases in children. The PeDRA Annual Conference is central to achieving these goals and will include didactic lectures, interactive discussions led by experts in research methodology, poster sessions, and disease-focused small-group meetings. The specific aims are: 1) To provide new and established PeDRA investigators with an essential knowledge base and infrastructure to conduct high-quality multicenter research in pediatric skin disorders; 2) To create a bridge between basic scientists and clinicians to enhance opportunities for translational research initiatives; and 3) To identify and prioritize the clinical needs and therapeutic opportunities in four disease- specific areas: inflammatory skin diseases, hemangiomas, epidermolysis bullosa, and disorders of keratinization. An additional goal is to expand the research mission beyond the established working groups to other disorders with need.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Pediatric Dermatology Research Alliance (PeDRA) was established to promote and facilitate high-quality, collaborative clinical, translational and basic science studies to improve the health outcomes of children with skin disease. The Annual Meetings proposed here will provide training for current and upcoming investigators in the design and conduct of multicenter clinical research protocols. They will facilitate research groups in prioritizing research needs, in establishing partnerships with bench scientists and patient support groups, and in initiating clinical studies and drug trials for both common and rare skin diseases. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The need for better therapies for children with skin disorders will be most effectively addressed by well- designed and well-executed clinical trials administered by a collaborative network of committed investigators with input from disease-advocacy organizations. Currently there is a need for more FDA-approved therapies for the treatment of pediatric skin disorders such as severe inflammatory skin diseases and disfiguring vascular birthmarks. In addition, there is a lack of clinical care guidelines for rare inherited skin diseases that can be life-endangering. Standardized treatment protocols and methods to measure response to therapy do not currently exist for most conditions and clinicians must rely on case reports and expert opinions when determining therapeutic intervention. Individual disease-specific working groups have successfully conducted preliminary research studies in these populations. While the idea for a broader more inclusive umbrella pediatric dermatology research organization has been under discussion for several years, investigators recently recognized that the time was ripe to form an expansive research consortium across the profession to allow talents to be further pooled and the Pediatric Dermatology Research Alliance (PeDRA) was founded. The goal of PeDRA is to create sustainable collaborative research networks, which will promote and facilitate high-quality clinical studies for pediatric skin diseases by educating investigators, providing opportunities for translational research initiatives and identifying and prioritizing clinical needs and therapeutic opportunities. The proposed meetings will provide training in the design and conduct of multicenter clinical research protocols for practicing clinicians, scientists, and pediatric dermatology fellows. They will serve as a forum to communicate advances in basic research that are ripe for translation and will foster cooperative efforts. The PeDRA meetings will facilitate the prioritization of research needs, the development of consensus-derived treatment protocols, and the planning of clinical studies and trials. Finally, they will provide a venue for the critical review and refinement of ongoing research endeavors via discussion and idea-sharing with expert speakers and other attendees. The Specific Aims of these scientific meetings are: 1. Aim 1: To provide new and established PeDRA investigators with an essential knowledge base and infrastructure to conduct high-quality multicenter research in pediatric skin disorders. Year 1 will focus on teaching key strategies for recruiting and retaining study participants, navigating the IRB and writing grant proposals, as well as developing an infrastructure for multicenter collaborative research. Year 2 will focus on best practices in clinical study design including outcome measures and data analysis. In each year, pilot and early project ideas will be discussed with input from experts and disease advocacy groups. Aim 2: To create a bridge between basic scientists and clinicians to enhance opportunities for translational research initiatives. Year 1 will focus on discussion of latest findings and breakthroughs in basic science with relevance to pediatric skin disease, identifying areas for translation. Year 2 will focus on refining and implementing collaborative projects. Aim 3: To identify and prioritize the clinical needs and therapeutic opportunities in four disease- specific areas: inflammatory skin diseases, hemangiomas, epidermolysis bullosa, and disorders of keratinization. Year 1 will focus on prioritizing clinical needs and implementing a pilot project for each research area. Year 2 will focus on design and initiation of a high-priority multicenter clinical study or trial, including determination of appropriate outcome measures.